Cross-path reactive chromatography/mass spectrometry as a versatile platform for characterization of primary and higher order structure of complex heterogeneous proteins

PROJECT SUMMARY
High-throughput characterization of increasingly complex and heterogeneous protein structures (including both
primary and higher order structures) is now required in a variety of fields ranging from personalized medicine
(biomarkers) to industrial-scale production of recombinant proteins (for both product quality control and feedback
adaptive process control). However, extensive structural characterization usually involves several multi-step
processes that are both time- and labor-consuming, and frequently cannot be implemented in a high-throughput
format. Additional complication arises from the presence of multiple protein sub-populations in the
analytical/clinical/production sample, which may exhibit altered functional or biophysical properties despite
having very similar structural characteristics (e.g, small soluble aggregates, aberrant glycoforms, disulfide-
scrambled species, etc.). The proposed research aims at developing a robust and versatile analytical technology
using the novel cross-path reactive chromatography (XP-RC) platform with on-line detection by electrospray
ionization mass spectrometry (ESI MS) augmented by protein ion manipulation in the gas phase (including both
conventional top-down MS/MS and the limited charge reduction technique developed in our laboratory). XP-RC
allows protein chemical modifications (such as disulfide reduction, covalent labeling, H/D exchange, etc.) to be
combined in-line with the separation step and enables real-time MS measurements that are not adversely
affected by components incompatible with the ESI process. This is achieved by utilizing the unique elution
characteristics (retention) of proteins and small-molecule reagents in non-denaturing chromatographic media
(size exclusion or ion exchange); during their retention the proteins can be exposed to various reagents to induce
the desired modification(s) in a highly controlled fashion. Our preliminary data provide strong evidence that
multiple reactions can be carried out inside a single column in a sequential manner by exposing the protein to
multiple reagent plugs as it moves through the column prior to MS detection/characterization of the modified
protein. The initial efforts will be focused on implementing differential in-line reduction of disulfide bonds followed
by free thiol capping with isotopically labeled reagents for high-throughput disulfide mapping and glycoform
profiling (Aim 1). These efforts will be then extended to enable selective reduction of inter-chain disulfides while
preserving the non-covalent interactions and internal disulfides in complex protein systems to enable
identification of binding partners within such systems; MS/MS detection will allow binding interfaces within such
selectively preserved complexes to be localized (Aim 2). An alternative approach will utilize in-line chemical
labeling as a means of localizing the binding interfaces. Lastly, the XP-RC/MS platform will be used to implement
dilution-free H/D exchange characterization of protein complexes and small soluble aggregates in the top-down
fashion (Aim 3).

Public health relevance
PROJECT NARRATIVE Reliable characterization of both covalent structure and conformation of complex heterogeneous proteins is required in a variety of fields ranging from personalized medicine to industrial-scale production of recombinant proteins. Extensive characterization involves multi-step processes that are both time- and labor-consuming and are usually a poor fit for a high-throughput format. The proposed research will make a critical contribution towards streamlining protein analysis at a variety of levels by developing a versatile platform that is based on cross-path reactive chromatography (where protein modifications are carried out in-line) with real time detection by mass spectrometry.